ROLE OF GTP-BINDING PROTEINS IN INTRACELLULAR TRANSPORT

The long term objective of this project is to elucidate the mechanisms of intracellular transport of proteins in eukaryotic cells. Biochemical and genetic evidence demonstrates that small, ras-like, GTP-binding proteins are involved in this process. The objective of this proposal is to identify and functionally characterize (a) GTP-binding protein(s) involved in the transport of proteins through the Golgi. The major experimental system will be a cell-free transport assay that measures the transfer of proteins between cis and medial Golgi compartments. The non-hydrolysable analog GTPgammaS inhibits transport in the cell-free system; current evidence suggests that this effect is mediated by the binding of a cytosolic GTP-binding protein to an effector on the membrane. The specific aims of the project are to (1) Purify the GTP-binding protein using its inhibitory effect on the cell-free transport assay, (3) Use the pure protein to obtain a cDNA and specific antibodies in order to study the function of the GTP-binding protein in the transport reaction. (5) Study the regulation of nucleotide exchange on the GTP-binding protein that is responsible for its activation. (6) Identify the effector to which GGBF binds tightly on the membranes in order to study its role in transport. The cell-free transport assay provides a system with which to functionally characterize specific GTP-binding proteins. The work described in the proposal paves the way for one of the first detailed description of the mechanism of action of a small GTP-binding protein of the ras super-family.